Developing Cyclopeptide Nef Inhibitors to Facilitate HIV-1 Eradication

PROJECT SUMMARY:
While currently available antiretrovirals block viral replication and thus control HIV-1 infection, they do not cure
the disease; latent reservoirs of replication-competent virus persist. To eradicate HIV-1 infection, novel an-
tiretrovirals must be developed. These drugs would ideally induce the killing of infected cells once latency is
reversed. An attractive direction in developing such antiretrovirals is the inhibition of the HIV-1 Nef protein. By
modulating surface-levels of immune receptors, Nef enables infected cells to evade host defense mechanisms.
Among the many functions of Nef, surface downregulations of CD4 and major histocompatibility complex class
I (MHC-I) are the most prominent and presumably most relevant in antiretroviral drug discovery. By downregu-
lating CD4 from the cell surface, Nef enables CD4-induced epitopes of the viral Env protein to remain con-
cealed, which renders infected cells less sensitive to antibody-dependent cellular cytotoxicity (ADCC). By
downregulating MHC-I, Nef disrupts host antigen presentation so that infected cells are protected from killing
by cytotoxic T lymphocytes (CTLs). Conceivably, therapeutic inhibition of these Nef functions may restore the
activities of ADCC and CTLs, thus facilitating the detection and clearance of infected cells. Crystal structures
solved by us showed that Nef-mediated downregulations of CD4 and MHC-I involve a common site on Nef. In
each case, however, this site is remodeled by Nef’s association with target-specific, hijacked clathrin adaptor
proteins (APs) to uniquely accommodate the intended substrate. Furthermore, when bound to Nef, both the
CD4 cytosolic tail and the MHC-I cytosolic tail adopt curved, near-circular postures, which suggests that this
multifunctional site of Nef is structurally poised to bind curved peptide sequences. We therefore hypothesize
that cyclic peptides mimicking these cytosolic tails may function efficiently as inhibitors to block the correspond-
ing cellular activities of Nef. Cyclic peptides (or cyclopeptides) are a promising, novel class of therapeutics,
which are uniquely capable of disrupting protein-protein interactions. Importantly, high-affinity cyclopeptide in-
hibitors can be developed efficiently using recently established strategies. In this project, we will develop such
cyclopeptide-based Nef inhibitors. Our specific aims are: 1) use our established MOrPH-PhD platform to
screen and select CD4-mimetic cyclopeptide inhibitors that bind to the Nef/AP2 complex in high affinity, and
solve high-resolution crystal structures of the cyclopeptide-bound Nef/AP2 complexes to enable structure-
based derivatization of the inhibitors; 2) use the same work flow to develop and optimize MHC-I-mimetic cyclo-
peptides into potent inhibitors, which block recruitment of MHC-I into the Nef/AP1 complex; 3) use cell-based
assays to characterize the identified Nef inhibitors for their efficacy, cell permeability, and cellular toxicity, and
then use the knowledge learned to guide further derivatizations for improved properties. Successful completion
of this work should yield cyclic peptide-based Nef inhibitors with high affinity in vitro and significant efficacy in
cells, which could ideally be developed into novel antiretrovirals with unique therapeutic potentials.

Public health relevance
PROJECT NARRATIVE: Current antiretrovirals, although effective in controlling HIV-1 infection, do not cure the disease. Antiretroviral drugs blocking essential functions of the viral protein Nef, if developed successfully, may revitalize immune de- fense mechanisms and thus open up the possibility for a cure. This project is designed to develop such an- tiretroviral therapeutics in a novel and promising format, namely cyclic peptides.